Genetic analysis in families with neurological disease

The identification of gene mutations causing disease lends new insight into the pathogenesis and etiology of the disorder under examination. In collaboration with NINDS and NHGRI we are performing a whole genome scan of families with a variety of neurological diseases. We assessed two families with Parkinson's disease (PD), a large kindred from Columbia with Blepharospasm and a family with dystonia associated with pain. The genome wide scan in these families is being performed in collaboration with the linkage analysis core of LNG using a 5cM linkage panel and is currently 80% complete. Data management and analysis is being performed using a custom database and linkage interface designed by the bioinformatics and computational biology core of LNG.[unreadable] [unreadable] We have identified a region of linkage within chromosome 4 in a large in-bred PD family, a region containing a segregating haplotype on chromosome 3 in the blepharospasm family and a segregating haplotype on chromosome 17 in the dystonia family. In collaboration with Drs Wood and Perez-Tur we identified the gene LRRK2 which underlies PARK8 linked Parkinson's disease. THis has subsequently been shown to cause >1% of sporadic PD and >5% of familial PD.